Characterization and prevention of Chemotherapy-Induced Damage to Ovarian Reserve

Abstract:
Cancer therapy-induced ovarian insufficiency is a major public health problem affecting millions of women
over their reproductive life span. Our overarching aim is to understand and prevent the damage caused by
cancer treatments and to extend that knowledge to prevent ovarian aging. In the prior period, we successfully
achieved all specific aims and showed: i) Breast cancer chemotherapy but not tamoxifen alone induces a
significant decline of ovarian reserve; ii) Women with BRCA mutations have fewer primordial follicles in their
ovaries, which accumulate more DNA damage with age compared to controls, and, iii) they experience greater
ovarian reserve loss after chemotherapy; iv) Selective knock-down of BRCA1 renders oocytes more liable to
chemotherapy-induced death; v) Gonadotoxic chemotherapy causes primordial follicle death by inducing DNA
double strand breaks (DSBs), which prompts apoptotic follicle death in primordial follicles but not by activation
of their growth in the acute phase. In addition, vi) A ceramide-induced death pathway inhibitor Sphingosine-1-
Phosphate (S1P) prevents chemotherapy-induced human ovarian follicle death, likely by enhancing the ATM-
Pathway. Given the shared mechanisms through DNA damage and repair, these findings opened new avenues
in the prevention of chemotherapy-induced damage to gonadal function, and, to reverse, retard or prevent
reproductive aging. In the current renewal, we aim to further these studies with the following translational aims:
1. To determine whether the mutations in BRCA1 vs. BRCA2 or other key members of the ATM-mediated DNA
DSB Repair Pathway result in the increased susceptibility to chemotherapy-induced ovarian reserve loss and
oocyte death in women with breast cancer; 2. To determine differences in the molecular mechanisms of acute
and delayed chemotherapy-induced human primordial follicle loss; 3. To test the efficacy and mechanism of an
FDA-approved S1P analogue, FTY-720, in the prevention of chemotherapy-induced human ovarian reserve
loss. To achieve these translational aims we will combine clinical studies with studies of basic, translational
mechanisms using in vivo human ovarian xenograft models, laser-captured individual-oocyte RNA sequencing
and single-cell quantitative real-time PCR approaches which evolved in our laboratory during the past funding
periods. These translational studies with human material will be mechanistically strengthened with an in vitro
mouse oocyte gene-interference and genotoxicity assay (GTA), which we also developed and validated in the
past funding periods. This translational proposal will not only expand knowledge of the mechanisms and
prevention of chemotherapy- induced ovarian damage but also result in a paradigm shift in our understanding
of how ovarian germ cells mitigate genotoxic stress in general. The exploitation of such mechanisms, in addition
to leading to new fertility preservation strategies, will provide new insights into future discoveries to moderate
reproductive, and potentially, somatic aging.

Public health relevance
Narrative: Chemotherapy-induced premature menopause and infertility are major sources of health problems. If the mechanisms of chemotherapy-induced oocyte death as well the pathways to repair and prevent such damage are understood, quality of life of cancer survivors can be greatly enhanced. The same knowledge would also enable us to moderate reproductive aging for all women and can also provide insights into the prevention of overall aging.